17th Fellows Forum on Osteoporosis and Other Metabolic Bone Diseases

This application seeks support for the 17th Fellows Forum on Osteoporosis and
Metabolic Bone Diseases. The conference will be held October 10-11, 2023,
immediately prior to the Annual Meeting of the American Society of Bone and Mineral
Research in the Vancouver Convention Center, Vancouver, British Columbia, Canada. It
will be a live, in-person event. We expect to have approximately 60 postdoctoral trainees
who are united by their research interests but who are training in a number of different
basic and clinical specialties. The faculty will consist of 12 of the most highly valued
thought leaders in the world. The ability of young investigators with promise to interact
with this faculty in a setting of both didactic and interactive workshops has been and will
continue to be a seminal experience, leading to a further commitment on the part of
these fellows to train in osteoporosis and other metabolic bone diseases.

Public health relevance
The application seeks support for the 17h Fellows Forum on Osteoporosis and Metabolic Bone Diseases that will be held at the Vancouver Convention Center, Vancouver, British Columbia, Canada, October 10-11, 2023